NIDA TASK ORDER FOR SYNTHESIS AND DISTRIBUTION OF DRUGS OF ABUSE AND RELATED COMPOUNDS. N01DA-18-8944. PERIOD OF PERFORMANCE: JUNE 9, 2020 - JUNE 8, 2

TO 06 for Synthesis and Distribution of Drugs of Abuse and Related Compounds.